USE OF HIVIG FOR THE PREVENTION OF MATERNAL-FETAL HIV TRANSMISSION

To evaluate the effect of combination therapy with HIVIG and ZDV on the transmission of HIV infection to infants born to HIV infected women.